Elucidation of mutant p53-medidated mechanisms in promoting metastatic esophageal cancer

PROJECT SUMMARY
Esophageal Squamous Cell Carcinoma (ESCC), the predominant subtype of esophageal cancer worldwide is
one of the most known lethal cancers. The prognosis of metastatic ESCC is dismal with a 5-year relative survival
rate of only 5%. Mutations in TP53 (mouse homolog Trp53), which are detected in approximately 70% of ESCC
patients, contribute to tumor metastasis and poor prognosis. To understand the mechanisms of Trp53R172H-
mediated metastasis, which is one of the “hotspot” mutations in ESCC, we utilized mouse models and performed
RNA-Seq on metastatic ESCC cells generated from this model, from which I identified Colony stimulating factor-
1 (Csf-1) to be significantly upregulated. While it is canonically involved in polarization of tumor-associated
macrophages through binding to its receptor CSF-1R, my data demonstrate the existence of autocrine signaling
that is potentially co-regulated by epigenetic reader Bromodomain-Containing Domain 4 (BRD4). The
overarching hypothesis of this study is that CSF-1/CSF-1R autocrine signaling is one of the major mechanisms
by which missense TP53 mutations can promote invasion and lung metastasis in ESCC. I will test this hypothesis
through the following interrelated Specific Aims: (1) Elucidate the role of Trp53R172H-mediated CSF-1/CSF-1R
signaling pathway in promoting invasion and lung metastasis in ESCC, (2) Investigate BRD4 as a candidate co-
regulator of Trp53R172H that contributes to CSF-1 upregulation and assess the anti-tumorigenic efficacy of
inhibiting BRD4, and (3) Delineate the tumorigenic, as well as epigenetic/transcriptomic states mediated by
missense p53 mutations recurrent in ESCC patients and impact upon CSF-1/CSF-1R signaling. To accomplish
Aim 1, I will assess the role of CSF-1/CSF-1R signaling in proliferation, migration, primary tumor and 3D organoid
formation, invasion and lung metastasis, as well as its downstream effectors through utilizing in vitro and
complementary in vivo approaches. I will accomplish Aim 2 by studying the direct interaction of p53-R172H and
BRD4, and also their shared DNA binding motifs through CUT&RUN-Seq. Additionally, I will genetically delete
and pharmacologically inhibit BRD4 to evaluate their effects on tumorigenesis and lung metastasis. To
accomplish Aim 3, I will introduce p53 mutations through base editing and evaluate their distinct roles in pro-
oncogenic activities. I will also investigate how these mutations affect the transcriptional expression of factors in
CSF-1/CSF-1R signaling pathway during metastasis, and also conduct single-cell ATAC-Seq on mouse primary
and metastatic tumors to evaluate their chromatin accessibility. This study will elucidate the tumor cell intrinsic
mechanisms underlying ESCC metastasis, which will ultimately open new avenues in developing therapeutic
strategies for metastatic ESCC patients that can be extended to other SCCs. I will develop skills in analytical
thinking, technical approaches, scientific communication, grant and manuscript writing, and mentorship with the
support and resources available through my sponsors, advisory committee and graduate program, which will be
critical to accomplish my long-standing career goal to become a tenure-track faculty to conduct cancer research.

Public health relevance
PROJECT NARRATIVE Esophageal cancer is a devastating disease with the majority of patients being diagnosed after the tumor has metastasized, leaving patients with the 5-year relative survival rate of only 5%. The proposed work seeks to better understand the underlying mechanisms of metastasis in esophageal carcinoma, as well as to target the identified pathway in pre-clinical models. Overall, in the long term, this study will introduce more effective and targeted treatments to patients with metastatic esophageal cancer, and potentially other deadly cancers with similar genetic and epigenetic properties.